NATIONAL NEUROLOGICAL AIDS BANK

Project Summary/Abstract
Human immunodeficiency virus (HIV) remains a global threat to human health and an important cause of
neurologic and psychiatric disorders, despite advances in longevity due to the use of antiretroviral therapy (ART).
ART suppresses HIV replication and allows for partial immune restoration, but may fail to achieve adequate
penetration of the central nervous system (CNS). Currently, ART does not eliminate latent HIV, does not clear
viral reservoirs, and does not normalize the inflammatory response. Further, some ART may have neurotoxic
effects. For these reasons, HIV-associated disorders of the CNS and peripheral nervous system (PNS) have
persisted and evolved despite the use of ART in the aging HIV+ population.
In order to cure HIV infection of the CNS and to elucidate the pathogenic mechanisms of CNS and
PNS disease in ART-treated patients, as well as to continue ongoing studies of aging and HIV co-
morbid conditions, NeuroAIDS investigators require a continuous and reliable source of well-
characterized human tissues, fluids, and data. These invaluable resources are provided by the
National Neurological AIDS Bank (NNAB), a member of the National NeuroAIDS Tissue Consortium
(NNTC). Over the past 19 years, the NNAB has enrolled 806 participants, and currently follows a
cohort of 171 active participants who have agreed to be tissue donors. Most of our donors have
received serial, pre-mortem medical, neurologic, neuropsychologic and laboratory examinations.
NNAB has also performed 259 tissue harvests of cohort members. Over the past 5 years, the NNAB
has distributed 3,766 frozen tissue specimens, 853 fixed tissue specimens, 23,007 formalin fixed paraffin
embedded tissue slides and 3,065 aliquots of fluids to NNTC-approved, qualified investigators.
The NNTC is a consortium of 4 geographically dispersed clinical sites and a Data Coordinating Center
(DCC). Over the past 5 years, NNTC has collectively fulfilled 123 specimen requests that generated 128
publications. The NNAB actively collaborates with the other NNTC clinical sites and the DCC to develop
and maintain standard study protocols, to transfer data to the DCC, to review investigator requests for
NNTC resources, and to allocate such resources in a fair and timely fashion. The NNTC works with the
DCC to insure we maintain an accurate specimen inventory, and to support the harmonized central NNTC
database. The NNAB looks forward to working with our participants, our colleagues, and our requesters
for another 5 years to expand and develop this priceless and indispensable scientific resource.

Public health relevance
Project Narrative In order to cure CNS HIV infection and to elucidate the mechanisms of HIV neuropathogenesis under ART, investigators require a reliable source of annotated human tissues, fluids, and data. The National Neurological AIDS Bank (NNAB) has supplied these resources for 2 decades and will continue to do so in the future.